Household income, financial stress and physiologic aging markers in low income adults across the life course

One-third of US adults are low-income and age earlier than their higher income peers, but it is not clear if
increasing available household income could improve their health. Earlier aging is believed to be due, in part,
to financial stress, or stress induced by insufficient income for basic needs. However, physiologic response to
financial stress is untested. Research in this area requires knowledge of both health disparities and biology of
aging and poses unique methodological challenges. Since it is not possible to randomly assign adults to
differing income or financial stress levels, innovative methodologies must be used to evaluate their effect. The
proposed research outlines three natural experiments leveraging existing physiologic biomarker data from
population-based samples to ask distinct, but related, questions testing the theoretical concept of ‘weathering’
over the adult life-cycle.
The first experiment tests the hypothesis that stress-sensitive biomarkers are higher during times of higher
routine end-of-the-month financial stress in low-income older adults aged 70-79 by capitalizing on biomarker
data from the Health, Aging and Body Composition Study and monthly Social Security payment timing. The
second experiment quantifies cortisol response to a non-routine source of financial stress (i.e. an event that
poses a risk to an individual’s financial situation) in low-income middle-aged adults, using MIDUS II data,
based on four days of repeated cortisol samples and daily diary data, accounting for confounding. The third
experiment exploits 2009 policy changes that expanded Supplemental Nutrition Assistance Program (SNAP)
eligibility and benefits (participation increased 3% and benefits increased 16%) for some, but not all, lowincome
adults to test stress- and nutrition-sensitive biomarker response to increased income. Biomarker
changes over time will be compared in young and middle-aged low-income adults aged 18-59 who likely were
and were not eligible for increased income.
Within the fertile and well-suited environment of Johns Hopkins University, the application proposes training to
(1) add biology of aging knowledge to my existing health disparities knowledge, enabling me to respond to an
NIA priority area by conducting innovative research at the intersection of these two fields of study, and (2) add
training developing and evaluating natural experiments using traditional clinical trial methods, causal inference
and econometric modeling to my existing epidemiologic training, equipping me to independently investigate
non-randomized exposures, such as income and financial stress, and develop effective interventions to
improve the lives of low-income adults. The proposed research and training respond to NIA’s call to elucidate
mechanisms contributing to disparities across the life-cycle.

Public health relevance
The proposed research and training seek to launch a program of research investigating causal links between income, financial stress and physiologic aging with a long-term goal of advancing health disparities science towards meaningful interventions for low-income adults. To accomplish these goals, I seek training in developing and evaluating natural experiments using traditional clinical trial methods, causal inference and econometric modeling and training in biology of aging, which will complement my existing epidemiologic and health disparities training. The proposed research outlines three natural experiments that leverage existing physiologic biomarker data from population-based samples to ask distinct, but related, questions about physiologic aging in low-income adults.